Visual pathway cooperation to align viewing strategies and processing specializations for predation

Project Summary
Vision arises from the combination of viewing and visual processing. How animals align viewing strategies with
regional processing specializations to accomplish specific behavioral tasks is unclear. We recently discovered
that mice use binocular vision to pursue and capture insects. Here, we follow up on this discovery to understand
the retinal signals and downstream pathways that mediate binocular vision for predation (Aim 1) and control the
gaze to keep targets within the binocular visual field (Aim 2). Mammalian binocular vision relies on the presence
of ipsilaterally projecting retinal ganglion cells (RGCs). We recently reported that nine of the 40+ mouse RGC
types have ipsilateral projections. Here, we test the hypothesis, that two ipsilaterally projecting RGC types, the
sustained ON and sustained OFF alpha (sONα- and sOFFα-) RGCs, guide binocular predation. We have
developed intersectional transgenic tools to selectively label, silence, and remove the ipsilaterally projecting
sONα- and sOFFα-RGCs (~300 cells, ~0.6% of RGCs). The sONα- and sOFFα-RGCs show increased density
and acuity (i.e., reduced receptive field size) in the ventrotemporal retina. In Aim 1, we will combine transgenic
and immunohistochemical labeling and high-resolution imaging of whole retinas to understand the organization
of the sONα- and sOFFα-RGC acute zone in the ventrotemporal retina. We will analyze how sONα- and sOFFα-
RGCs encode local, global, and combined motion individually and as populations with targeted patch clamping
and two-photon calcium imaging. Visual stimulus parameters will be based on analyses of our large 3D tracking
dataset of mice hunting crickets. Next, we will assess the binocular processing of sONα- and sOFFα-RGC signals
by specific neurons in the superior colliculus, the retinorecipient target mediating predation. Finally, we will
measure the contributions of ipsilaterally projecting sONα- and sOFFα-RGCs to predation using selective
silencing and removal and 3D behavior tracking. In Aim 2, we will test the hypothesis that ON-OFF direction-
selective (DS-) RGCs control the gaze to keep prey within the binocular visual field during pursuit and capture.
Combining two-photon calcium imaging and immunohistochemistry, we will analyze the topographic maps of
DS-RGC direction preferences around the sONα- and sOFFα-RGC acute zone. We will use targeted patch clamp
recordings and two-photon calcium imaging to understand how ON-OFF DS-RGCs encode local, global, and
combined motion stimuli with ethologically relevant parameters and in vivo electrophysiology to analyze the
transformation of their signals by specific neurons in the superior colliculus, which mediates gaze shifts. Finally,
we will test the impact of removing direction selectivity from ON-OFF DS-RGCs on gaze control during predation.
Our studies will reveal how two conserved RGC subclasses, their regional specializations in the retina (acute
zones and topographic direction preference maps), and downstream pathways cooperate to align viewing
strategies and visual processing for an essential survival behavior.

Public health relevance
Project Narrative This proposal aims to decipher how two conserved output pathways from the retina to the brain cooperate to control gaze and mediate high-acuity binocular vision in a complex behavior (i.e., predation). Insights into the organization and function of visual pathways in health facilitate the identification of early disorganization and dysfunction in common diseases of the retina and the brain. In addition, knowledge about the function of specific pathways in visually guided behaviors establishes benchmarks for comparing competing strategies for vision restoration.